Impact of Integrated Pet Care on Glycemic Control and Diabetes Responsibility

Project Summary/Abstract
There is a critical need to develop innovative strategies in early adolescents with type 1 diabetes mellitus (T1DM)
that develop self-efficacy and facilitate positive parental involvement. In the absence of accessible interventions,
we can expect adherence to diabetes self-management tasks (like blood glucose monitoring [BGM] and BG
review) to decline and glycemic control (hemoglobin A1c [HbA1c]) to deteriorate, as typically seen during
adolescence. The objective of this pilot RCT is to assess the feasibility, acceptability and preliminary effects of
incorporating the structured care of a pet fish into a family-based diabetes self-care routine combined with
communication skills training (Routine+CC) on HbA1c, BGM frequency and BG review in early adolescents with
suboptimal control of T1DM. The rationale for the intervention is based on three established principles: Social
Cognitive Theory, Habit Formation Theory, and Family Systems Theory. Participants in the Routine+CC group
will be given a Betta fish with supplies. Participants will be told to feed their fish in the morning/evening/bedtime
and perform BGM at that time; and perform fish tank maintenance activities once a week in collaboration with
their parent(s) and review their blood glucose (BG) trends with the parent at that time utilizing a collaborative
communication framework. The hypothesis is Routine+CC will have high recruitment, fidelity and retention
rates; and will provide activity-based cues to perform BGM and BG review, a positive competence experience
that enhances self-efficacy in performing diabetes self-care tasks, and an opportunity for positive parental
engagement in the youth’s diabetes care. The hypotheses will be tested by pursuing these specific aims: Aim
1: Conduct a rigorous feasibility and acceptability pilot RCT of (a) Pet Fish + Collaborative Communication
(Routine+CC) (n=20) which combines routine (pairing fish care with family-based diabetes self-care tasks) and
collaborative communication (family will receive training on collaborative communication skills); (b) Pet Fish
(Routine) (n=20) which only has the routine; as compared to (c) Control (n=20) which is usual care. Obtain
quantitative and qualitative feedback on feasibility (recruitment, fidelity, retention) and adolescent/caregiver
acceptability; and Aim 2: Assess the preliminary effects of the Routine+CC intervention on HbA1c, BGM
frequency and adherence to weekly BG review at intervention completion (12 weeks) plus a follow-up period (12
weeks). Examine whether Routine+CC changes the hypothesized target mechanisms (parental involvement,
diabetes self-efficacy, habit strength) based on survey measures. This approach is innovative, because it
proposes a novel approach for youth with TIDM that is resource-efficient and home-based, offers new concepts
in habit-formation research and presents a potential benefit of pet care for children with chronic conditions. The
proposed research is significant because it is expected to provide the necessary quantitative and qualitative data
related to intervention feasibility, acceptability and preliminary efficacy data that will directly inform and ensure
the success of a subsequent larger fully powered multi-site randomized efficacy trial.

Public health relevance
Project Narrative Early adolescence is a high-risk time for deterioration of blood glucose levels in young people with type 1 diabetes (T1DM). This application will assess the feasibility, acceptability and preliminary effects of an intervention that incorporates the structured care of a pet fish into a family-based diabetes self-care routine combined with communication skills training on glycemic control, blood glucose monitoring frequency and blood glucose review in early adolescents with T1DM and elevated blood glucose levels. It is expected that the proposed study will provide information to guide a subsequent larger multi-site randomized clinical trial to evaluate efficacy of the intervention.